Interaction of fibroblasts with cell corpses increases collagen synthesis during lung repair

PROJECT SUMMARY
Repair after injury is a fundamental biologic process that is critical for maintaining lung health. Fibroblasts must
perform key pro-repair functions after injury including proliferation and synthesis of new extracellular matrix,
particularly collagens, that scaffold wound closure. Dead cells (collectively termed cell corpses) are produced
during lung injury and inflammation and have been shown to promote the transition from inflammation to repair.
Prior research has focused on understanding macrophage interactions with apoptotic corpses. However, non-
professional phagocytes including fibroblasts can also interact with cell corpses and the consequence of these
interactions in the lung has not been studied. This proposal seeks to address unknowns regarding fibroblast-
corpse interactions and their role in healthy lung repair. We have found that recognition of cell corpses by
fibroblasts causes fibroblasts to increase collagen protein synthesis. Our preliminary data support a mechanism
where the phosphatidylserine receptor Axl binds cells corpses, activates polyamine metabolite synthesis,
increasing intracellular spermidine levels, which fuel hypusination. Hypusination occurs on a single protein: the
ribosomal subunit eiF5a. When hypusinated, eiF5a is able to stabilize translation of poly-proline-repeat proteins
including collagen. Hypusination is also important for cell proliferation. Blocking polyamine synthesis prevented
hypusination of eiF5a in response to corpse recognition. Blocking Axl or hypusine-eiF5a prevented the increase
in collagen in response to corpse recognition. We also show that, in vivo, hypusine-eiF5a is increased in
fibroblasts after lung injury and that collagen deposition and alveolar-capillary repair are reduced when
hypusination is blocked with the inhibitor GC7 or through targeted deletion of the hypusination enzyme
deoxyhypusine synthase in fibroblasts. This led us to hypothesize that interaction of fibroblasts with cell corpses
is a central cue that activates fibroblast proliferation and collagen synthesis following lung injury, facilitating
repair. We will use three aims to test if 1) corpse recognition via Axl triggers a translationally-regulated increase
in collagen protein, 2) corpse recognition drives polyamine synthesis that increases spermidine that increases
hypusine-eiF5a and stabilizes collagen translation, and 3) to fully activate pro-repair programming fibroblasts
require the ability to sense corpses via Axl, synthesize polyamines via ornithine decarboxylase, and hypusinate
eiF5a via deoxyhypusine synthase in order to proliferate and synthesize new extracellular matrix after lung injury.

Public health relevance
PROJECT NARRATIVE Cell death is an obligate consequence of tissue injury and fibroblasts are important cells during tissue repair. This proposal tests the hypothesis that fibroblast recognition of dead cells, termed cell corpses, promotes fibroblast repair capacity by triggering elevation of polyamine synthesis and hypusination of eiF5a, which drives fibroblast proliferation and synthesis of collagen proteins. Achieving the aims of this proposal will enhance our understanding of fibroblast-corpse interactions and the role of hypusine-eiF5a in fibroblasts and pave the way for development of novel approaches to promote lung repair.